Ion Channels in Context: Structure and function in native cells and macromolecular complexes

ABSTRACT
This proposal requests funds to support the 75th Annual Symposium of the Society of General Physiologists
(SGP), entitled “Ion Channels in Context: Structure and Function in Native Cells and Macromolecular
Complexes.” The meeting will be held on September 7-11, 2022 at the Marine Biological Laboratory (MBL) in
Woods Hole, MA. The SGP symposium has an established reputation as the leading meeting for physiologists,
cell biologists, and biophysicists across all career stages and professional arenas. Each year the meeting topic
is unique. In this way, SGP Symposiums highlight timely and emerging topics while leveraging a proven logistical
structure, excellent administrative support, and an established base of potential attendees.
The 2022 conference will bring together approximately 175 scientists and trainees to discuss novel and
fundamental research pertaining to ion channel function in the context of native cells. The size of the meeting,
and the venue at the MBL allow presentation of a diverse range of research topics within an environment that
maximizes interactions between investigators of different career levels and promotes individual discussions. The
overarching goal of the 2022 meeting is to highlight emerging concepts and tools that will promote advances in
understanding of how ion channels function in cellular environments. Kurt Beam (National Academy of Sciences,
University of Colorado) will deliver the endowed SGP “Friends of Physiology” keynote address. His work on
excitation-contraction coupling in skeletal muscle embodies the concept of ion channels working within a
macromolecular complex to accomplish a coordinated and fundamental physiological process. The meeting
organizers and co-PIs, Drs. Catherine Proenza (University of Colorado) and Matthew Trudeau (University of
Maryland) are experts in the field of ion channel function and regulation. They have assembled an enthusiastic
group of invited speakers who study a wide range of ion channels in different physiological systems. The invited
speakers reflect the commitment of the organizers and the SGP to promoting diversity and equality: 49% are
women and 24% are under-represented minorities. Invited speakers also include investigators at all career
stages (early 22%, mid 24%, senior 54%). Sessions at the meeting will cover channel function in native cells,
channel regulation and allostery, and channel function in disease states. An important goal of the meeting is to
foster development and provide opportunities for trainees. To these ends, the schedule includes 3 poster
sessions, 24 short talks selected from submitted abstracts, and 2 career development workshops. The specific
aims of the symposium are (1) To discuss cutting-edge advances pertaining to ion channel function in
physiological contexts; (2) To foster new and interdisciplinary conversations and collaborations; and (3) To
Promote early-career investigators and enhance diversity.

Public health relevance
PROJECT NARRATIVE This proposal requests funds to support the 75th Annual Symposium of the Society of General Physiologists (SGP) entitled "Ion Channels in Context: Structure and Function in Native Cells and Macromolecular Complexes", which will be held September 7-11, 2022 at the Marine Biological Laboratory in Woods Hole, MA. The overarching goal of the symposium is to extend structure and biophysical knowledge of ion channels into their physiological context, in which they work in concert with other cellular elements. The meeting will thus increase fundamental understanding of ion channel function in physiological systems and facilitate translation of basic science findings into pre-clinical studies and clinical initiatives.